Towards an integrated analytics solution to creating a spatially-resolved single-cell multi-omics brain atlas

PROJECT SUMMARY
The maintenance and function of the nervous system depends on cell-cell interactions among
neuronal and non-neuronal cell populations, which occur through physically binding cell membrane surface
or secreted proteins, triggering signaling cascades that activate cell-type gene regulatory programs. The
cell-cell interactome responds and regulates the microenvironment which is altered in physiological
processes such as brain development and aging, or during the onset and progression of different
neuropsychiatric disorders. Although great progress has been made in dissecting cellular heterogeneity
through single-cell transcriptome and epigenome profiling, a spatial atlas deciphering the gene regulatory
programs that mediate cell-cell interactions among neuronal and non-neuronal cell populations in the human
nervous system is lacking.
New technologies have been developed to generate transcriptome-scale gene expression profiles
with high spatial resolution in the original tissue context, thus greatly facilitating the structural
characterization of the tissue microenvironment as well as mechanistic investigation of cell-cell interactions.
Spatial transcriptomics technologies are increasingly used by the NIH Brain Research through Advancing
Innovative Neurotechnologies (BRAIN) Initiative and viewed as an important component of the cell atlas
building effort. Integrative analyses of spatial transcriptomics and multi-omic data have great potential in
constructing a complete spatially resolved brain atlas. However, it remains challenging to systematically
analyze, compare, and integrate data generated by different groups, in part due to the significant variation
in technology platforms and data analysis pipelines.
In previous work, our lab has developed Giotto as a powerful toolbox for comprehensive spatial
transcriptomics analysis. In this project, we propose to use Giotto as the basis to create a cloud-based
software platform and further develop new pipelines to facilitate harmonizing and integrating BRAIN Initiative
datasets. The specific aims are: 1. To develop a cloud-based software platform for harmonizing spatial
transcriptomics data analysis and visualization; 2. To elucidate the gene regulatory networks mediating cell-
cell interactions in the brain through integrated spatial multi-omic analysis; and 3. To create a benchmark
system for objective evaluation of spatial transcriptomics technologies and data analysis pipelines. Taken
together, our proposed research will generate powerful computational tools that will not only help BRAIN
Initiative investigators to construct a spatially resolved brain atlas but also enable the broad community to
efficiently utilize the rich resources generated by the BRAIN Initiative in their own research.

Public health relevance
PROJECT NARRATIVE This project will develop new computational tools to facilitate access, analysis, visualization, and integration of BRAIN Initiative data. This will allow the biomedical community to maximally utilize this rich resource in their own research in order to gain mechanistic understanding into brain organization and function in health and diseases.